Chromatin Regulation of Immune Cells in Myocardial Inflammation

PROJECT SUMMARY
Ischemic heart disease following myocardial infarction (MI) is a leading cause of global morbidity and mortality.
During MI, infiltrating immune cells, particularly monocytes, differentiate into macrophages, adopting both
reparative and maladaptive pro-inflammatory roles. These maladaptive immune responses can drive chronic
inflammation, adverse remodeling, and ultimately heart failure (HF) progression. Although blocking monocyte
recruitment has been explored as a therapeutic strategy, this approach risks impairing the essential reparative
functions required for proper wound healing and scar formation post-MI. Thus, understanding chromatin and
gene regulatory mechanisms controlling monocyte differentiation and macrophage activation is critical for
developing therapies that selectively target maladaptive pro-inflammatory responses while preserving reparative
functions.
BRD4, a member of the BET protein family, is a key epigenetic regulator of chromatin dynamics and transcription
during inflammation. Our preliminary data show that BRD4 plays a pivotal role in shaping pro-inflammatory
macrophage phenotypes during MI. While pharmacological BET inhibition using JQ1 can reduce inflammation
and improve cardiac function, systemic toxicity limits its therapeutic potential. To address this, we use a novel
Brd4 conditional allele combined with the Ccr2creERT2 mouse model to achieve monocyte-specific BRD4
deletion.
The goal of this project is to elucidate BRD4-mediated chromatin and gene regulatory networks (GRNs) that
control monocyte differentiation and macrophage function during MI and to identify therapeutic strategies that
selectively modulate maladaptive inflammation. Aim 1 will define how Brd4 deletion in CCR2+ monocytes affects
macrophage fate and cardiac function post-MI, using flow cytometry and scRNA-seq to track macrophage
differentiation and assess physiological impacts. Aim 2 will investigate BRD4’s role in regulating macrophage
activation, combining CUT&RUN and CRISPR interference to map BRD4 binding and its influence on MHC-II
gene expression and other pro-inflammatory programs. Aim 3 will use proteomics to identify BRD4 protein
interactors in macrophages, focusing on PU.1, to understand how it modulates BRD4 function during pro-
inflammatory activation.
This work will generate a comprehensive map of BRD4-regulated transcriptional and chromatin dynamics in
immune cells, providing new therapeutic targets that limit maladaptive macrophage activation, reduce chronic
inflammation, and improve outcomes in HF patients.

Public health relevance
PROJECT NARRATIVE Heart failure (HF) remains a major public health challenge, with high rates of morbidity and mortality worldwide. This research aims to uncover the epigenetic mechanisms that drive maladaptive immune responses after myocardial infarction, with a specific focus on BRD4 and its role in cardiac macrophage function. By identifying novel therapeutic targets, this work has the potential to guide the development of more precise treatments that reduce chronic inflammation and improve outcomes in HF patients.